Molecular Imaging of Fibrosis for Improved Treatment Planning of Pancreatic Ductal Adenocarcinoma

Pancreatic ductal adenocarcinoma (PDAC) is an invasive and rapidly progressive malignancy with a five-year
overall survival of less than 9% despite long treatment course and recent therapeutic advances. Unfortunately,
currently available imaging methods do not reliably evaluate the tumor response to neoadjuvant treatment. This
further requires surgical exploration and repeated biopsies for post-chemoradiotherapy (CRT) staging.
Additionally, the conventional anatomical imaging tools underrepresent the local extent of the tumor, which leads
to suboptimal tumor volume measurement for definition of the field of radiotherapy. Therefore, a non-invasive
imaging tool for precise evaluation of treatment response and tumor size measurement is of utmost need. High
degree of fibrosis, mainly collagen type I, has been recognized as the hallmark of PDAC. Tumor-associated
fibrosis further increases in response to neoadjuvant CRT and is correlated with improved outcome in patients
with PDAC. Building on this knowledge, the current proposal aims to develop an image-guided paradigm for
improving tumor delineation and monitoring treatment response in PDAC using a novel collagen I specific PET
imaging probe, 68Ga-CBP8. This project, if successful, paves the way to provide a non-invasive and more
accurate imaging tool to guide clinicians with optimized treatment planning, reduced cost of care and side effects
of repeated invasive procedures, and ultimately improved outcome. We hypothesize that 68Ga-CBP8 PET
imaging is a reliable and repeatable method that specifically targets and quantifies PDAC-associated fibrosis.
Using the dynamic 68Ga-CBP8 PET imaging and kinetic modeling, we hypothesize that imaging PDAC can be
optimized for static imaging with much shorter acquisition time. In our second aim of the grant, we hypothesize
that 68Ga-CBP8 PET imaging precisely quantifies the increased PDAC fibrosis following neoadjuvant CRT and
thereby could be used as a surrogate of treatment response. Lastly, we will explore whether 68Ga-CBP8 PET
imaging results in more precise tumor delineation by providing more accurate gross tumor volume measurement
compared to the conventional CT or MRI when correlated to the tumor size on histopathology gold standard.
This research will be performed by Dr. Shadi Abdar Esfahani, a nuclear medicine and abdominal radiologist at
Massachusetts General Hospital. She will be exceptionally mentored by Dr. Peter Caravan, a pioneer in PET/MR
molecular imaging of fibrosis, and co-mentored by Dr. Kenneth Tanabe, a pancreas surgeon and leading expert
in clinical trials and biomarker validation for pancreatic cancer. Building upon the strong clinical experience and
solid pre-clinical research on molecular imaging of cancer models, Dr. Esfahani’s goal is to become an
independent physician-scientist by developing a program for translational, quantitative PET/MR imaging of novel
cancer biomarkers with the ultimate goal of improving clinical care and outcome. This K08 award will provide her
with the training and mentorship needed to achieve independence and apply for her first R01.

Public health relevance
Pancreatic ductal adenocarcinoma (PDAC) is an invasive and rapidly progressive malignancy that remains highly lethal despite recent therapeutic advances. There is an urgent and unmet clinical need for more reliable and accurate imaging tools to optimize delineation of the tumor and non-invasive evaluation of response to neoadjuvant chemoradiotherapy. The purpose of this study is to develop an image-guided paradigm using a novel collagen specific PET imaging probe to address these needs with the ultimate goal of improved management and clinical care of PDAC patients.